Administration Core

Project Summary/Abstract
Expanding a talented research workforce focused on kidney, genitourinary tract, and benign
hematological diseases, trained in critical scientific approach, in emerging concepts, and in
advanced experimental approaches is fundamental to addressing the personal and socio-
economic burdens associated with these diseases. Toward this end, we will create a
comprehensive training program that encompasses research training in science related to
nephrology, urology, and hematology across the lifespan entitled the Philadelphia Program for
Mentored Research Training in Kidney, Urologic, and Hematologic Diseases (PERFORM-KUH).
The program will be located principally on the geographically unified campuses of the Children’s
Hospital of Philadelphia (CHOP) and the University of Pennsylvania (PSOM). Administered by a
team located at CHOP and PSOM, it will include trainers from CHOP, the University of
Pennsylvania, Temple University, Jefferson University, Drexel University, Wistar Institute and Fox
Chase Cancer Center. The PERFORM-KUH Administrative Core will provide overall leadership
and administrative support that will establish and maintain the PEFORM-KUH training program,
its integrated cores, and the Philadelphia community of KUH research trainees and faculty
mentors it serves. It will: #1 Provide leadership, financial management, and administrative support
for PERFORM-KUH, its Administrative Core, TL1 Core, Professional Development Core, and its
Networking Core; #2 Convene and manage the PERFORM-KUH Steering Committee and
Subcommittees (i.e., Mentoring Oversight, Recruitment and Admissions, Summer Fellowship
Program; #3 Establish an External Evaluation Board (EEB) that will serve as the oversight
committee to whom the PERFORM-KUH Steering Committee reports at an annual meeting timed
to coincide with the annual program scientific retreat; #4 Ensure effective communication within
and external to PERFORM-KUH, using several approaches that include a sophisticated internally
and externally facing website; #5 Conduct a formal evaluation and feedback process of program
core elements and of educational content and methods, creating a dynamic learning system that
will help leadership understand PERFORM-KUH programmatic strengths and weaknesses and
facilitate ongoing improvement and innovation; and #6 Organize one annual meeting of the
consortium of KUH U2C-TL1 training programs.

Public health relevance
Training a talented research workforce focused on kidney, benign genitourinary tract, and benign hematological diseases is fundamental to addressing the health burdens associated with these diseases. Toward this end, we will create a comprehensive training program in Philadelphia that encompasses research training in science related to nephrology, urology, and hematology across the lifespan entitled the Philadelphia Program for Mentored Research Training in Kidney, Urologic, and Hematologic Diseases (PERFORM-KUH).